Admin Core - Sweeney_McNally(NU)

Abstract for Administrative Core (Core A)
The Administrative Core provides integration and management of activities for the MDSRC. It
promotes interactions and communications between the research and patient/advocacy
communities on both a national and local level. The Administrative Core maintains the Center
website to communicate the Center mission and the availability of training opportunities and
services available through our Shared Scientific Resource Core. The Administrative Core also
coordinates meetings with our Center Advisory Committee (CAC) that has scientific, clinical and
patient advocate representation. The CAC meets in-person and/or electronically once a year. The
Administrative Core also works in conjunction with our Center members to promote awareness of
muscular dystrophy research and the Wellstone Centers program in the patient/advocacy
communities. Our Administrative Core has developed outreach activities as well as meetings,
seminars, web-based information, and lab tours involving patients and their families interacting
with our investigators. The Administrative Core also manages the matching funds we have
received both internally and from patient advocacy groups.